Neuroimmune communication as a driver of lesion formation and macrophage colonization of the omentum in endometriosis-associated pain

PROJECT SUMMARY/ABSTRACT
Endometriosis is a painful gynecological inflammatory disease that affects up to 15% of people born with a
uterus. While effective for a fraction of patients, current therapies such as hormones and NSAIDs present several
side effects. Therefore, new medical therapies and targets that provide long-term benefit are still needed. Here,
we propose to validate drugs that block neuroimmune communication as well as macrophage-targeting drugs
as novel, non-hormonal, and non-opioid approaches for the treatment of endometriosis-associated pain. The
project also addresses a previous unknown mechanism by which CGRP contributes to a pro-endometriosis
phenotype in macrophages and pinpoints a nociceptor-responsive macrophage population that drives omental
colonization for subsequent pain and lesion formation in endometriosis. My preliminary data show that nociceptor
to macrophage signaling via CGRP/RAMP1 contributes lesion formation and endometrial cell growth. However,
the mechanisms by which CGRP programs (re)macrophages to a pro-endometriosis phenotype is not known.
Therefore, we will (Aim 1) identify the inflammatory mediators released and the signaling pathways activated in
macrophages upon CGRP stimulation using bulk RNAseq analysis. I will further use FDA approved drugs such
as pexidartinib to the measure the effect of macrophage-targeting in my mouse model. I also have preliminary
data showing that Maresin-1 (MaR1) a pro-resolving lipid mediator reduces pain and stimulates efferocytosis by
macrophages. I will next determine the mechanisms by which MaR1 resolves pain and inflammation in
endometriosis. For that, I will perform scRNAseq of MaR1-treated mice at different timepoints to understand the
dynamics and mechanism of pain resolution during endometriosis.
I also have preliminary scRNAseq data showing that endometriosis completely changes the immune cell
landscape in the peritoneal cavity with a decrease in the macrophages that migrate to the omentum. Therefore,
during my R00 phase (Aim 2) I will determine the extent to which neuroimmune communication drives omental
colonization by macrophages as well as pinpoint the nociceptor-responsive population of macrophages in the
omentum that is responsible for endometriosis pain and lesion formation. I will then use transgenic mice to
deplete that macrophage population to determine the extent to which those cells contribute to pain and lesion
formation. To reach these long-term goals, I have outlined a detailed career development plan, which will provide
me with the technical and leadership skills to establish a successful research laboratory. The K99 phase of
research will be conducted under the excellent co-mentorship of Drs. Michael Rogers and Clifford Woolf. My
Research Advisory Committee and collaborator are leading experts in neuroimmune communication (Dr. Chiu),
endometriosis (Dr. Missmer), and pharmacology of pain and neuroimmune communication (Dr. Cunha). This
K99/R00 award will provide me key support for my successful transition to an independent investigator studying
neuroimmune communication during endometriosis.

Public health relevance
PROJECT NARRATIVE Endometriosis is a painful gynecological inflammatory disease with limited therapeutic options that affects up to 15% of people born with uterus. Here, we propose to validate CGRP/RAMP1 blocking drugs as well as macrophage-targeting drugs as novel non-hormonal and non-opioid approaches for the treatment of endometriosis-associated pain. The project also addresses a previous unknown mechanism by which CGRP contributes to a pro-endometriosis phenotype in macrophages and pinpoints the specific nociceptor-responsive macrophage population that drives omental colonization.